Real Time Phylogeny and Contact Tracing to Disrupt HIV Transmission

Real Time Phylogeny and Contact Tracing to Disrupt HIV Transmission Kantor, Rami MD
SUMMARY
HIV transmission remains a global challenge, and innovative approaches within constrained public health
systems are needed for its disruption. Though actual transmission networks are unknown, characterizing social
and phylogenetic networks can guide public health interventions towards preventing HIV transmission. Contact
tracing is the current public health tool to derive and characterize social networks and identify, notify, test and
link to care partners of those newly diagnosed. Analysis of molecular HIV clusters by genetic distance-based
methods is now recommended in the US to detect outbreaks as part of ending the HIV epidemic. However, the
added value of phylogenetic (beyond distance-based) cluster analyses and how they may focus and benefit
routine (beyond outbreaks) public health activities to reduce transmission is an existing knowledge gap. In the
prior cycle we started to address this gap, established a strong academic-governmental Partnership in Rhode
Island, developed a bioinformatics pipeline to share and analyze statewide data, and for the first-time routinely
and in near-real-time conducted cluster analyses, identified recent HIV diagnoses who were part of molecular
clusters, and attempted to re-interview all of them, to increase their motivation and enhance contact tracing. The
important finding that despite better cluster detection a re-interview was not beneficial, together with our
achievements in the prior cycle, informed and refocused this Renewal, guiding its restructured scope. In this
Renewal, leveraging the Partnership we established and our gained experience, we propose to redesign our
bioinformatics pipeline to routinely and in near-real-time conduct cluster analyses and integrate molecular data
with typically siloed clinical and public health data, use them to prioritize all individuals and clusters with new
sequences, use this prioritization to inform tailored and intensive public health interventions, and evaluate the
impact of these processes, while improving representation and phylogenetic inference of the local and regional
epidemic. We hypothesize that these innovative approaches will focus restricted public health efforts and more
efficiently identify and link to care persons unaware of their HIV status, persons aware but not linked to care, or
persons at high risk of getting infected. The Specific Aims to address this hypothesis are to: (1) Redesign the
pipeline and conduct near-real-time cluster analyses in and beyond Rhode Island; (2) Leverage the redesigned
pipeline to evaluate the added value of routine, near-real-time integration of cluster analyses prioritizing public
health interventions; and (3) Augment phylogenetic inference by increased sequence availability and more
comprehensive analyses. Our approach is strengthened by a multidisciplinary experienced team of public health
officials, ethicists, clinicians, statisticians, bioinformaticians, behavioral scientists, evolutionary and molecular
biologists, with infrastructure and expertise developed in the prior cycle. This Renewal, built on a strong Ethics
Platform, will have high impact on the care continuum; bring Rhode Island closer to zero new HIV infections; and
serve as a model for larger jurisdictions, as we aim to end the HIV epidemic in Rhode Island and beyond.

Public health relevance
Real Time Phylogeny and Contact Tracing to Disrupt HIV Transmission Kantor, Rami MD NARRATIVE This Renewal will take advantage of our achievements from the prior grant cycle, and evaluate the benefits of integrating and prioritizing molecular, clinical, and public health data to guide resource-constrained public health interventions and disrupt HIV transmission in Rhode Island. The strong Partnership established in the prior cycle between the state’s Department of Health and its academic institutions, combined with multidisciplinary expertise, existing data, and experience from the prior cycle, will be the basis for the continuation of this important work. The proposed approach will significantly enhance the public health impact of this research and help bring small Rhode Island closer to getting to zero new HIV infections, while serving as a model for larger states.